Philadelphia Regional Center for Children's Environmental Health

The Administrative Core of Philadelphia Regional Center for Children's Environmental Health (PRCCEH), at
the University of Pennsylvania Perelman School of Medicine in collaboration with Children's Hospital of
Philadelphia (CHOP) and seven regional universities, will be directed by the Center Directors, Drs. Rebecca
Simmons and Aimin Chen, and Deputy Director Dr. Marilyn Howarth to ensure that the mission of the
center is achieved. The Center promotes the translation of scientific knowledge in children's environmental
health (CEH) through engagement with target audiences of communities and community organizations, health
care providers, schools and teacher organizations, and policy makers. Engagement activities will be
accomplished using multiple formats including website, social media, in person educational sessions,
webinars, testimony on science to policy makers, in home evaluations and direct child intervention. The Center
focuses on four primary research areas for translation: asthma prevention, lead exposure and harm reduction,
air pollution, and endocrine disrupting chemicals. The AC promotes efforts in the Development Core (DC) to
provide a catalyst program to support innovative pilot projects and development of new translational strategies.
The AC strengthens DC's mission to cultivate the next generation of children's environmental health scientists,
providing career development mentorship for early stage and under-represented minority investigators. The AC
supports the Translation Core (TC) to engage with stakeholders for knowledge translation and advocate for its
separate pilot project program to test and evaluate translational products. The AC will leverage institutional
administrative resources to ensure fiscal oversight, manage resources, and build research and translational
capacity in CEH by overseeing Center membership. The AC fosters collaboration through workshops,
seminars, and symposia. Furthermore, it evaluates the center activities by self-study and scheduling meetings
of the Internal Advisory Committee which includes members from Center for Research on Reproduction and
Women's Health, Children's Hospital of Philadelphia, Center of Excellence in Environmental Toxicology
(CEET), social science and policy, communication, and a community representative. As a part of the national
Children's Environmental Health Research and Translation (CEHRT) network, the PRCCEH will interact with
the Coordination Center and other CEHRT Centers to share translational products and practices. The Center
Administrative Core ensures success by the following specific aims: Aim 1: Enhance the institutional, regional,
and national identity of Philadelphia Regional Center in the area of Children's Environmental Health; Aim 2:
Leverage and complement institutional administrative resources; Aim 3: Maintain a vibrant Center membership
by seeking new members and prioritizing services; Aim 4: Organize workshops, annual symposium, and
seminar series to facilitate collaborations; Aim 5: Support Development Core and Translation Core mission of
CEH translation; Aim 6: Enhance administrative efficiency and interact with other CEHRT centers.